Defining the role of RIG-I in glaucoma pathogenesis and response to viral infection

ABSTRACT:
Immune mechanisms have been identified as increasingly important features in the pathogenesis of glaucoma
and ocular hypertension. Rare immunogenetic syndromes, including Singleton-Merten syndrome (SGMRT),
provide a window into the role of the innate immune system in glaucoma. We recently identified 3
multigenerational pedigrees with isolated juvenile glaucoma or SGMRT. These families all carry missense
variants at the same amino acid residue of the DExD/H-box RNA helicases RIG-I, but have varying phenotypic
spectrum. We found that these variants activate RIG-I and downstream Type I interferon signaling in the
absence of exogenous RNA ligands, and a mouse model of one of these variants recapitulates features of
SGMRT including elevated IOP and glaucomatous retinal ganglion cell loss. In this proposal, we seek to
extend our findings by (i) defining the molecular mechanism by which RIGI variants cause glaucoma in our
mouse model using genetic perturbation, histologic, and single cell transcriptomics analyses; (ii) defining the
triggers that exacerbate SGMRT and may explain the phenotypic variability of this condition, including viral
infections such as Zika virus; (iii) testing therapeutic interventions to rescue the sequela of RIG-I activation and
glaucoma in patient cells and our mouse model. Our underlying hypothesis is that RIG-I activation in
fibroblasts, macrophages, and endothelial cells in the trabecular meshwork and Schlemm’s canal lead to Type
I interferon signaling, increased in intraocular pressure, and glaucoma. We additionally hypothesize that these
pathways can be exacerbated by Zika infection or dsRNA triggers and rescued by Type I interferon blockade.
Our overarching goal is to define the immune mechanisms that drive glaucoma. This proposal will inform our
understanding of the contribution of the immune system to SGMRT as well as more common forms of
glaucoma that may be driven by RIG-I activation.

Public health relevance
NARRATIVE: Glaucoma is a leading cause of blindness worldwide and the innate immune system has an unclear role in glaucoma pathogenesis. By using mice and human cell lines to study a rare inborn error of immunity that features glaucoma, we will contribute to understanding the role of innate immunity in the pathogenesis of glaucoma. These studies will inform our understanding of gene/environment interactions in glaucoma and identify novel classes of therapeutics that can be used to target subtypes of glaucoma.